Mechanism of transcription and related gene expression processes in bacteria and human mitochondria

Project Summary
The synthesis of RNA by RNA polymerase (RNAP) and folding of that RNA into its biologically functional three-
dimensional shape go hand in hand. The kinetics of RNA synthesis determine the folding outcome, and are
influenced by myriad factors, such as intracellular temperature, pH, concentrations of small molecules and
proteins in the cell, and the exact sequence of DNA being transcribed into RNA. Transcription is not a continuous
process: RNA synthesis by RNAP is interrupted by sequence-dependent pauses, during which the polymerase
remains bound to the nucleic acids without active nucleotide addition occurring. These pauses create windows
of time for regulation of transcription to occur. Our research program will address at the atomic level the pausing
mechanisms and contribution of pausing to co-transcriptional events, such as folding of RNA. The first direction
of the program aims to develop tools for capturing and visualizing RNA folding intermediates during transcription
and to understand the effect of pH on the kinetics of RNA synthesis by RNAP, and thus the RNA folding pathway.
The resulting tools will be of broad interest to the RNA community because they can be applied to follow folding
of other biologically important RNAs. The second direction will apply those tools to map co-transcriptional RNA
folding differences in “healthy” and mutated human mitochondrial transfer RNAs (mt-tRNA), thus providing the
structural basis for disease-causing mt-tRNA mutations. Additionally, we will assess the contribution of
mitochondrial RNAP pausing to the differential folding of unmutated and disease-variant mt-tRNA, thus
expanding the arsenal of regulatory roles transcriptional pausing plays in this key organelle. Finally, the third
research direction will address how the balance between transcription of mitochondrial DNA and its packaging
is achieved to cater to the ever-changing cellular needs for energy. The completion of the proposed research
will be transformative to the understanding of the basic principles of gene expression, as well as to the
applications in synthetic biology and to the molecular mechanisms of diseases linked to mitochondrial DNA.

Public health relevance
Project Narrative Transcription, a process by which RNA polymerase (RNAP) converts the information stored in the DNA (or RNA) into an RNA message, is critical to the survival of all organisms. The speed with which RNAP makes RNA determines the three-dimensional shape into which RNA folds and consequently whether or not the RNA product can be used for downstream gene expression processes; however, our understanding of the interplay between RNAP kinetics and co-transcriptional RNA folding is lacking. In the proposed project, we will develop novel tools for capturing structural snapshots of RNA folding intermediates and apply them to study RNA folding and function in bacteria and human mitochondria, with ultimate insights into the underlying causes of mitochondrial diseases and applications in engineering microbes for synthetic biology, diagnostic, and therapeutic applications.